Dynamic epigenomic landscape of opioid abuse following early-life adversity

PROJECT SUMMARY
The last decade has seen a devastating epidemic of opioid addiction in the U.S with the fatal opioid overdose
incidence doubling in 10 years. Genetic factors clearly contribute to addiction vulnerability, but they alone cannot
account for this rise. Therefore, environmental factors must also play role, and their enduring effects would be
maximal during sensitive/critical periods early in life. Indeed, early life adversity (ELA) is associated with opioid
addiction vulnerability, and in experimental models, it promotes such vulnerability. Although the responsible
mechanisms have yet to be elucidated, the enduring nature of changes set in motion by ELA strongly suggest
that epigenetic mechanisms may underlie these stable changes. The epigenome is a signal integration platform
superimposed on the genome, which is modified by both ELA and drugs of abuse, and which also encodes
aspects of sex differences. Epigenetic mechanisms are known to establish stable changes in cell function (via
coordinating gene regulation) that give rise to persistently altered behaviors, including drug use and drug seeking
behaviors. Thus, understanding epigenetic and transcriptional changes associated with addiction propensity
following ELA may answer several key questions about the causes and mechanisms of opioid use disorder
(OUD). For example, how is ELA epigenetically encoded, thereby increasing risk for opioid abuse and relapse-
associated behaviors? Does heroin differentially affect the epigenome and transcriptome in those with ELA
history, promoting this vulnerability? These questions will be addressed here using robust rat models of ELA and
of heroin self-administration and relapse. Capitalizing on our findings that ELA augments heroin vulnerability and
relapse in a sex-divergent manner4, consistent with human data20-23, we will test the driving hypothesis that both
ELA and initial heroin use regulate epigenomic processes, and these, in turn, coordinate gene regulation that
ultimately affects cellular signaling, and OUD-like behaviors. The epigenomic and transcriptomic changes
induced by ELA and heroin will be determined by employing both bulk- and single-cell multi-omics in selected
brain regions at different points in the OUD trajectory. They will be complemented by sampling of CSF and blood
extracellular vesicle (EV) miRNA profiles to enable potential development of predictive markers of OUD risk
and/or progression. Using state of the art sequencing and analysis methods, we will uncover gene regulatory
networks associated with ELA, initial heroin use, and heroin abuse/relapse in females and males. This approach
will allow us to identify novel targets for OUD prevention and intervention in vulnerable individuals.

Public health relevance
PROJECT NARRATIVE This decade has seen an explosive, devastating epidemic of opiate addiction in the U.S. Effective strategies to mitigate this epidemic must include both prevention (identifying addiction-prone individuals early and intervening effectively) and treatment, but few strategies for either currently exist. Using state of the art sequencing technology and robust rat models of heroin abuse and relapse, we ask how psychosocial stress early in life sex- dependently impacts gene expression networks to promote opioid use disorder (OUD)-like behavior, and potentially open new therapeutic avenues for OUD.